Achilles Tendinopathy Center of Research Translation

ABSTRACT
Current treatment strategies for Achilles tendinopathy seek to modulate the tendon mechanical environment to
promote healing and regeneration. However, a lack of fundamental understanding of tendinopathic
mechanobiology limits optimization of rehabilitation strategies and impedes development of targeted mechano-
therapeutics. This proposal will address these gaps using orthogonal experiments across human tendinopathy,
rat overuse, and mechanistic mouse models. The proposed studies will establish a framework to inform
mechanotherapeutic strategies and identify novel signaling targets. Tendinopathy, particularly caused by
overuse, often results in tissue microdamage. This microdamage, in turn, impairs transmission of tensile
mechanical signals through the tissue, resulting in under-loading of endogenous tendon cells. Our preliminary
data show that tendon cells exhibit a biphasic response to tendon de-tensioning. De-tensioning causes a
transient loss in cytoskeletal tension and mechanotransductive signaling, resulting in upregulation of matrix
degrading enzymes like matrix metalloproteinases. Subsequently the tendon cells attempt to re-tension the
matrix by cytoskeletal contraction and matrix re-organization. This biphasic response represents a novel
framework for understanding the development, progression, and translational intervention of tendinopathy. In
the proposed studies, we will 1) determine how tendinopathic disease impacts Achilles tensional homeostasis
across the spectrum of disease, 2) define the mechanotransductive mechanisms, and 3) determine how
rehabilitative loading restores Achilles tensional homeostasis for translational impact. Using our expertise in
tenogenesis and tendinopathy (Dyment) and mechanobiology (Dyment/Boerckel), this translational project will
provide a comprehensive understanding of the mechanotransductive mechanisms that drive aberrant and
chronic matrix remodeling during Achilles tendinopathy, define mechano-response benchmarks in controlled
assays that may predict clinical patient outcome, and identify potent drug targets for the next generation of
tailored mechanotherapeutics to complement the current gold standards of physical therapy and surgery.

Public health relevance
Narrative The Achilles Tendinopathy Center of Research Translation (AT-CORT) at the University of Pennsylvania will foster fundamental discoveries to guide clinical translation, as well as develop and employ novel translational resources, models and technologies, to address the highly significant research and clinical challenge of Achilles tendinopathy. The Overall goal of the AT-CORT is to develop new insight and technologies that uncover the mechanobiologic basis of Achilles tendinopathy across length scales, from the nucleus, to the cell, to the tissue microenvironment to patients. Together, our highly interdisciplinary team, innovative tools, and interactive Research Projects and Cores will dramatically advance knowledge, develop innovative tools and insight, and provide new directions for translation of new therapies to treat Achilles tendinopathy.